Oligodendrocyte heterogeneity in Alzheimer' s disease

Project Summary/Abstract
Neurodegenerative disease mechanisms encompassing Alzheimer’s disease (AD) are complex and have
remained largely unknown to date despite the identification of risk factors and genetic mutations associated with
the disease. Oligodendrocytes (ODCs) have critical roles in the central nervous system where they ensheath
axons to allow rapid saltatory conduction and also provide metabolic support to neurons. Although a largely
homogeneous oligodendrocyte population is thought to execute these functions throughout the brain, recent
reports suggests that ODCs are highly diversified cell populations in the brain. Using systems biology approach,
that integrates multi-omics data from human pathological specimens and mouse models of AD, this project aims
to generate single-cell resolution genome-wide maps of transcriptional and regulatory networks in ODCs
associated with AD. The project represents a major advance in the field by taking a comprehensive approach to
data-driven discovery to identify highly conserved regulatory programs of AD. In parallel, the project aims to
understand the role of sterol regulatory-element binding proteins (SREBPs) in AD using functional genomic
approaches. Finally, the project will identify novel cell-type specific transcriptional regulators of AD using cutting
edge approaches to data science.

Public health relevance
Project Narrative This project leverages advances in genomics and genetics to understand molecular mechanisms underlying neurodegenerative diseases like Alzheimer’s disease and unravel how oligodendrocytes are altered in disease. Using multiple layers of genomics data from human and mouse samples, we develop a framework for integrative study of neurodegenerative diseases and find potential regulators of the disease, which are likely to be novel drug targets.